Characterization of visual feature encoding in Drosophila Visual Projection Neurons LPLC1 and LPLC2

Abstract
A critical function performed by visual systems is the fast and reliable detection of features within the
environment, such as moving objects or approaching threats. Neurons predicted to encode these higher order,
behaviorally relevant visual features have been identified in a variety of species. However, a lack of cell-type
specific genetic tools, accessible neural anatomy, and clearly mapped neural circuitry has limited the
identification of these cell-types, and led to an incomplete understanding of the mechanisms which govern
feature encoding in visual systems. Here, we investigate visual feature encoding by leveraging Drosophila
melanogaster. We specifically investigate mechanisms governing visual feature encoding in visual projection
neurons (VPNs), a class of neurons predicted to selectively encode visual features. We focus on two VPN
populations, Lobula Plate/Lobula Columnar type 1 (LPLC1) and Lobula Plate/Lobula Columnar type 2 (LPLC2).
Previous studies have suggested these two neuron types encode the visual features of an object approaching
on a direct collision course, however their hypothesized selectivity to visual features and the origins of this
selectivity have yet to be thoroughly investigated. Differences in recording location and stimulus parameters
during Ca2+ imaging have made it difficult to resolve feature tuning across studies. Additionally, our preliminary
data that demonstrate these neurons are spiking, contrary to prior assumptions, suggest feature selectivity
may emerge from a spike timing code, which has to date been ignored. Thus, there is a critical need to study
these neuron populations using whole-cell electrophysiology and precisely designed stimuli to understand the
mechanisms governing their feature encoding and reveal their selectivity to specific visual features. The goal of
this project is to uncover feature tuning for these neurons at the level of individual spikes and
investigate the mechanisms governing their feature selectivity. To accomplish this goal, we will first map
the receptive fields of LPLC1 and LPLC2 and characterize responses to an array of visual stimuli to establish
their feature selectivity (Aim 1). Following this, we will investigate the mechanisms of inhibition that shape both
the feature and receptive field selectivity (Aim 2). Finally, we will investigate how neuron active properties
further govern feature selectivity within these neurons through multicompartment modelling (Aim 3). Findings
from our work will reveal the specificity and underlying mechanisms for feature encoding within two VPN types,
which may serve as a foundation for investigating feature detecting neurons in other, more complex species.
Drosophila possess a visual system with striking similarities to vertebrate visual systems, so our findings may
provide general principles for collision detection. In the longer term, a more fundamental understanding of
visual feature encoding in fruit flies may help the development of human therapeutics for those suffering from
blindness.

Public health relevance
Project Narrative Visual systems are tasked with detecting behaviorally relevant features among a plethora of visual information. This project seeks to understand how these behaviorally relevant features are encoded by investigating hypothesized feature encoding neuron populations in Drosophila (fruit fly). Fundamental mechanisms of feature encoding discovered here may help improve the development of human visual prostheses, leading to better treatment solutions for those suffering from blindness.